IGF::OT::IGF RESEARCH, DEVELOPMENT, PRODUCTION AND SUPPORT FOR CLINICAL TRIALS BROADLY NEUTRALIZING MONOCLONAL ANTIBODIES (BNMABS)

IGF::OT::IGF RESEARCH, DEVELOPMENT, PRODUCTION AND SUPPORT FOR CLINICAL TRIALS BROADLY NEUTRALIZING MONOCLONAL ANTIBODIES (BNMABS)